CE25-025 - Preventing ACES with Linkages and Stronger Systems (PALSS)

Project Summary/Abstract
This study brings together researchers and subject matter experts from NORC at the University of Chicago and
George Washington University with experience using innovative, integrated mixed research methods that
combine systems and complexity informed evaluation (SCIE) and culturally responsive equity evaluation
(CREE) approaches to evaluate community-level primary prevention interventions. In this project, the research
team will evaluate the Mississippi-based program, LINK. LINK is a community-level initiative to build
community capacity to prevent childhood adversity and maltreatment and promote health equity in Mississippi
by strengthening local primary prevention ecosystems of social and economic services and supports.
This project will fill a gap in the current community change literature by identifying the effectiveness of LINK—
an existing primary prevention approach that addresses community-level conditions and strengthens economic
supports to families—in preventing adverse childhood experiences (ACEs) at the county level. This objective
will be met by accomplishing the following aims:
Aim 1: To evaluate the systems-strengthening capabilities of the community approach, LINK, and identify
variations in LINK implementation and structure across Mississippi counties
Aim 2: To evaluate the impact of LINK on county-level child abuse and neglect (CAN) and domestic violence
(DV) rates
Aim 3: To evaluate the role of community capacity as a mediator of the effect of LINK on county-level CAN and
DV
To address Aim 1, this study will administer a survey of community capacity across the state of Mississippi,
document and describe LINK implementation, and conduct a thorough program and policy document and data
review. To meet Aim 2, this study will conduct county fixed effects outcome models using child welfare
administrative data to determine the effectiveness of LINK in reducing rates of child abuse and neglect and
domestic violence at the county level across Mississippi. To address Aim 3, the results of the state-wide
survey will be used to measure community capacity at the county-level, and this measure will be included in
outcome models as a mediator of the impact of LINK on CAN and DV rates. Finally, to address Aim 1 & 2,
qualitative, semi-structured interviews will be conducted to gain a deeper understanding of the outcomes
identified in previous analyses, and LINK’s connection to those outcomes, through a process called outcome
harvesting. These interwoven study activities are rigorous and equitable, ensuring community voice is present
at all phases of the research with a focus on understanding the role of building community capacity in
prevention of adversity and promotion of health equity at the community level.

Public health relevance
Project Narrative Preventing Aces with Linkages and Stronger Systems (PALSS) is an integrated, mixed methods study of LINK, a community-level initiative to build community capacity to prevent childhood adversity and maltreatment and promote health equity in Mississippi by strengthening local primary prevention ecosystems of social and economic services and supports. The results of this study will identify the effectiveness of an economic system strengthening program, like LINK, in preventing child abuse and neglect and domestic violence at the community level; it will also identify the role of strengthened community capacity in mediating the effect of LINK on child abuse and neglect and domestic violence and for whom LINK is most effective (e.g., communities with high income inequality, communities with significant housing instability). These findings will contribute to the field’s understanding of the value of building community capacity, particularly community capacity to support families’ economic needs, to prevent adverse childhood experiences (ACEs) from occurring and improve health equity for communities most at-risk of ACEs.